Evaluation of Transperineal Biopsy under Local Anesthesia, a Novel approach to Decrease Post-Biopsy Infections and Improve Cancer Detection

PROJECT SUMMARY/ABSTRACT
Prostate cancer is the most commonly diagnosed malignancy in U.S. men. There are approximately 1
million prostate biopsy (Bx) performed annually in the U.S. Almost all Bx are performed as an office based
procedure in under 15 minutes. The precision of Bx has improved over the last decade with the introduction of
MRI guidance/targeting of suspicious lesions within the prostate. However, significant limitations remain with
this approach, including a significantly increasing risk of post-Bx infection. This arises because more than 97%
of all prostate Bx are performed via a transrectal (TR) approach that introduces rectal bacteria with each pass
of the Bx needle into the sterile urinary tract. The current risk of post-TR Bx infection, even with antimicrobial
prophylaxis, is high at approximately 7% overall with 3% (30,000 men) requiring hospitalization annually.
Transperineal (TP) Bx is an alternate approach that eliminates the direct introduction of bacteria from the
rectum to the prostate. This approach, which is perfomed without antimicrobial prophylaxis, instead passes the
Bx needle through the perineal skin and pelvic floor. TP Bx has not been widely adopted for several reasons.
Historically, it has been considered too painful for patients in the clinic and thus was traditionally performed
under general anesthesia. The added time, inconvenience and cost has limited its national adoptance.
Second when TR Bx was initially adopted over 40 years ago, antibiotic resistance of rectal flora was not a
challenge. Beyond the potential for in-office TP Bx to significantly reduce or eliminate Bx infections, TP Bx may
also improve cancer detection as studies of TP Bx (performed under general anesthesia) demonstrate
higher detection rates for prostate cancer, particularly for anterior zone tumors, compared to TR Bx.
This is notable as anterior tumors are difficult to sample with TR Bx. Anterior tumors are also twice as likely to
occur in African American men. In fact, our research demonstrates that some of the outcomes disparities in
African American men may stem from an underdiagnosis of anterior prostate cancers. Although TR Bx is
used widely, it is associated with a significant and increasing risk of Bx infections due to growing
antibiotic resistance, highlighting the urgent need for a safer alternative approach to prostate Bx.
We have refined a TP Bx approach under local anesthesia with MRI-targeting/guidance without
the need for antibiotic prophylaxis. We hypothesize that TP MRI targeted Bx will: (1) largely eliminate
post-Bx infections and costly hospitalizations for urosepsis; (2) be performed in the office with similar
discomfort and non-infectious complications compared to TR MRI targeted Bx; and (3) have significantly
better detection of prostate cancer. A multi-center randomized controlled trial will be conducted to
evaluate in-office TP MRI targeted vs. TR MRI targeted Bx, the current gold standard. This has transformative
impact to change current standard of practice. The investigators have a track record for collaboration. The
environment comprises 4 high-volume, SPORE funded centers of excellence that serve diverse populations.

Public health relevance
PROJECT NARRATIVE Approximately one million transrectal prostate biopsies are performed annually in the U.S., and the risk of post- biopsy infection is increasing due to greater antibiotic resistance of rectal flora. Preliminary data demonstrates that a transperineal MRI-targeted biopsy approach under local anesthesia compared to the standard practice transrectal MRI-targeted prostate biopsy has a much lower risk of infection, comparable pain/discomfort and may improve detection of prostate cancer. Our pivotal randomized controlled trial will be the first prospective study to evaluate in-office transperineal MRI targeted prostate biopsy, and if our hypotheses proves true transperineal MRI-targeted biopsy will become the new standard of care and significantly reduce post-biopsy infections and increase detection of clinically significant prostate cancer.